Self-Assembled Multifunctional Biointerfaces

Research in the Zha Lab at Rensselaer Polytechnic Institute focuses on creating biomimetic materials and
processes that aid in studying, diagnosing, preventing, and treating disease. By leveraging the self-assembly
capabilities of rationally designed biomacromolecules, this research aims to create hierarchically structured
systems that are multifunctional.
This MIRA R35 for Early Stage Investigators project will support the exploration and development of new
approaches for enhancing the function of biomedical and biological interfaces. The approaches are based on an
interfacial phenomenon recently reported by the PI, whereby robust nanothin coatings are generated non-
covalently on surfaces by controlling the self-assembly of structural proteins such as silk fibroin. These coatings
can transform the physicochemical properties of a wide range of substrates under biocompatible conditions,
regardless of surface chemistry or topography and without specialized equipment. The research program will
explore coatings that: i) exhibit dynamic behavior mimicking the temporal complexity of cell signaling in biological
processes, ii) shield surfaces against unwanted macromolecular and cellular interactions, iii) improve
biocompatibility and bioactivity of cell-material interfaces, and iv) present or release bioactive payloads in a
sustained, controlled manner.
While the innovations developed by the research program are disease-agnostic and will have the potential
to address a wide range of biomedical challenges, three proof-of-concept topics using model systems will be
examined in this project. 1) Coatings with temporally orchestrated release of multiple neurotrophic factors will be
developed to control Schwann cell phenotype for nerve tissue regeneration. 2) Antifouling peptide motifs will be
discovered by combinatorial synthesis and machine learning to generate coatings that improve the long-term
performance of implanted biosensors. 3) Surfaces of living cells will be engineered by interfacial protein self-
assembly to enhance their viability and bioactivity in therapeutic applications. The outcomes of this research
program are expected to broadly yield versatile, modular tools for biomaterials development.

Public health relevance
Controlling the properties of biomedical interfaces is critical for studying, diagnosing, and treating disease. This research program aims to develop a versatile platform based on interfacial protein self-assembly for increasing the functionality of biomedical and biological surfaces. Proof-of-concept projects explored in the proposed work include enhancing nerve tissue repair using coatings with temporally orchestrated growth factor release, improving the long-term performance of biosensors, and engineering live cell surfaces to control cell fate in therapeutic applications.